Discovery of Novel Antibiotic Natural Products from Marine-Derived Fungi

Project Summary/Abstract
A major challenge facing the future of human health is the rise of antibiotic-resistant pathogenic bacteria. In 2017
the World Health Organization (WHO) published a list of twelve pathogens that will pose the greatest threat to
human health due to resistance to frontline treatments. The overall goal of this project will be to identify novel
fungal natural products that exhibit antibiotic activity towards the WHO pathogens. Natural products are
secondary metabolites produced by living organisms. These small molecule chemical entities have played an
important role in traditional medicine for thousands of years and are an essential part of the current therapeutic
arsenal for modern medicine. This project will achieve the overall goal through two areas of research. The first
area involves the development of a rapid dereplication method that reduces redundant fungal strains in culture
libraries to streamline biological screening. The second involves the identification of antibiotic drug-leads with
novel chemical scaffolds or that function through a unique antivirulence mechanism of action against the WHO
pathogens. Once completed, these two areas of research will be bridged to develop a fungal metabolite drug
discovery platform that will be used to promote future lines of biomedical research.

Public health relevance
Project Narrative Fungi are a rich source of structurally diverse secondary metabolites with a wide range of biological applications. This research will explore a large library of fungal metabolites and identify the chemical scaffolds that exhibit bactericidal or antivirulence activity towards antibiotic-resistant pathogenic bacteria that the World Health Organization has deemed the greatest threat to human health.